Collaborative Influenza Vaccine Innovation Centers (CIVICs) Component A: Vaccine Center

To support the design and evaluation of innovative candidate products and delivery platforms that aim to achieve durable, robust and broadly protective immunity against viruses.